Ecological Momentary Assessment of Quality of Life in Metastatic Breast Cancer

PROJECT SUMMARY
Despite advances in breast cancer prevention and treatment, thousands of people are either newly-diagnosed
with or progress to metastatic breast cancer (MBC). MBC can lead to significant decrements in quality of life
(QoL), a multidimensional construct including physical and emotional well-being. Given the incurable nature of
MBC, QoL is a critical outcome. Furthermore, data from our group and others demonstrate that individuals living
with MBC have unmet needs related to QoL and desire MBC-specific QoL resources and interventions. However,
little is known about changes in QoL over time in those with MBC. The longitudinal QoL data that do exist pri-
marily come from pharmaceutical clinical trials, and have two key limitations. First, clinical trials may include
selected, higher-functioning individuals with no significant comorbidities; thus, findings may not generalize to the
broader MBC population. Second, clinical trials typically assess QoL at time points that align with treatment
cycles. There is little data on changes in QoL between cycles of treatment. The proposed research addresses
this gap in the literature by collecting longitudinal QoL data from people living with MBC. In-depth data on QoL
concerns and intervention preferences of individuals with MBC will allow us to adapt and apply existing behav-
ioral interventions to this group, who are often excluded from cancer survivorship studies. Our long-term goal is
to support the experience of those living with MBC through behavioral interventions. However, additional data
on QoL are needed in order to identify the optimal content and timing of such interventions. Thus, the overall
objective of this application is to collect in-depth longitudinal, observational data on QoL in MBC. To achieve this
objective, we will pursue two specific aims using mixed methods. In Aim 1, we will use an innovative ecological
momentary assessment (EMA) measurement-burst protocol to collect QoL data in a sample of females with
MBC (N=120). EMA involves repeated sampling of subjects’ current experiences in real time, in subjects’ natural
environments. The measurement-burst design incorporates short periods (i.e., days) of intensive assessments
that are repeated longitudinally over longer intervals (i.e., weeks). In the proposed study, participants will com-
plete EMA bursts (3 prompts/day) once per week for four consecutive weeks. EMA bursts will assess overall
QoL and symptom severity (anxiety, depression, fatigue, pain interference, and physical function). In Aim 2, we
will conduct in-depth individual qualitative interviews with a convenience sample of Aim 1 participants (N=10) to
assess participants’ experiences with the EMA protocol and their preferences for a future intervention. We will
also explore the potential impact of self-monitoring on participants’ lived experiences with MBC. The proposed
study will provide pilot data for a future trial to adapt an existing behavioral intervention targeting QoL among
cancer survivors for metastatic breast cancer, and test the efficacy of the adapted intervention. This program of
research has the potential to increase our understanding of QoL in this population, ultimately enabling us to
identify targeted intervention strategies to improve QoL and reduce suffering.

Public health relevance
PROJECT NARRATIVE Metastatic breast cancer is treatable but incurable; for this reason, quality of life is a critical outcome. The pro- posed study will use an ecological momentary assessment (EMA) measurement-burst protocol to assess quality of life among females with metastatic breast cancer. These unique data will increase our understanding of quality of life in this population and accelerate the development of behavioral interventions specifically designed for metastatic breast cancer, ultimately enabling us to intervene in ways that improve quality of life and reduce suffering.